Statistical Methods for Epidemiolgic Study of Stroke

[unreadable] DESCRIPTION (provided by applicant): The primary goal of this continuing grant is to develop new statistical methods that handle missing data to better understand the mechanisms of neurological disorders, particularly stroke. The statistical problems to be investigated in this proposal arise from NIH-funded Northern Manhattan Stroke Study (NOMASS) in which the Principal Investigator has been participating. NOMASS started as a cross-sectional study for first time stroke patients, and was then extended to a case-control study by recruiting community controls via Random digit dialing method. Finally, both cases and controls are followed to observe recurrent stroke for cases and initial stroke for controls. We will consider missing data problems, which arise in each stage of design: cross-sectional, case-control, and prospective. Although these problems have frequently arisen in other fields as well, satisfactory solutions have not, as of yet, been found. [unreadable] [unreadable]